EVALUATION OF GANCICLOVIR FOR CONGENITAL CYTOMEGALOVIRUS

To determine the safe and efficacious dosage of ganciclovir for intermittent administration by central line to babies with congenital CMV and to determine the safety and tolerance of ganciclovir.